Altering electron-induced radiolysis to optimize cryo-EM/ET imaging

PROJECT SUMMARY
Living cells have a complex and often precise organization in space and time. Determining the three-
dimensional structure of proteins and other biomolecules, as well as understanding how they form functional
networks in vivo, is a major goal of modern biology. Answering these questions is paramount to understanding
both the normal functions of proteins, as well as their dysfunctions. Cryo-electron microscopy (cryo-EM) and
cryo-electron tomography (cryo-ET) are powerful imaging tools that enable visualization and structural
determination of native macromolecular complexes in vitro and in situ. Researchers use cryo-EM to resolve
isolated (macro)molecules at near-atomic or atomic resolution, whereas cryo-electron tomography can
visualize macromolecules and organelles inside unperturbed cells with molecular to near-atomic resolution.
Together, cryo-EM and cryo-ET have the potential to reveal a more comprehensive and detailed (atomic-level)
picture of the spatiotemporal organization and inner workings of cells. However, to fully realize the potential of
cryo-EM/ET imaging techniques, we need new tools and approaches that can address outstanding technical
limitations, such as radiation damage of frozen-hydrated biological specimens and the localization of specific
molecules in cryo-tomograms. Therefore, we will develop a new sample preparation strategy that can reduce
electron-induced radiolysis of frozen-hydrated specimens, thereby improving the resolution of cryo-EM/ET
images and/or the speed of structure determination (Aim 1). Additionally, we plan to develop a cloneable,
hyper-bubbling protein tag that would allow the precise localization of target proteins in otherwise noisy, and
difficult-to-parse, cryo-tomograms (Aim 2). We will then apply these new tools to biological model systems (i.e.
rapidly frozen and cryo-FIB milled E. coli and yeast cells) as proof of principle. The successful fulfillment of our
research aims will further enhance the revelatory power of cryo-EM/ET techniques and illuminate the complex
and dynamic relationship between molecular structure and function.

Public health relevance
PROJECT NARRATIVE In order to understand the function of molecules inside living cells (such as proteins and DNA), we need tools that can visualize these molecules at a high level of detail. Although cryo-electron microscopy and tomography imaging allow researchers to visualize the 3D structure of life-like preserved molecules, both purified and inside unperturbed cells, there are still technical limitations (e.g., localization and identification of molecules in cryo-tomograms) that can be improved. Therefore, we propose to develop new tools and strategies to address these limitations so that we can better understand the structure and function of biomolecules, and the inner workings of cells in health and disease, and to potentially use this knowledge to design effective therapeutic treatments.